Meharry Occupational Medicine Residency Training Program

Abstract
The NIOSH Training Program Grants (TPG) support occupational health programs to meet the
growing need for skilled occupational health providers and for health care for the workforce. The
Meharry Medical College Occupational Medicine residency program has been a proud recipient
of three NIOSH TPGs since 2008. In that time, the program has accomplished all of its goals
and has enabled high quality specialized training for a diverse group of over 40 physicians
practicing in a multitude of occupational medicine focus areas. Our graduates serve as local,
regional, and national leaders in major corporations, government, academia, industry, and
private practice. Meharry is the principal producer of minority occupational medicine physicians,
ensuring that as the diversity of the workforce grows, so will the population of providers who
deliver the services needed for their care.
Funding from the current proposal will enable us to continue to offer a structurally superior
curriculum that will consolidate gains made from our `Total Worker Health' strategy via first-rate
learning experiences in clinical, research and service settings. The curriculum enhancement
and innovation will be inclusive of opportunities to affect positive changes in safety and health of
all workers, within and outside the workplace, including a focus on mental health and preventing
burnout among employees. Residents will participate in a newly developed rotation with the
Health and Wellness/Employee Assistance Program at Vanderbilt University Medical Center
that will help us build residents' knowledge and skills in employee mental health and wellbeing.
As well as enhance their participation in Prevention Leadership Advocacy Rotation. Residents
will be able to collaborate with other trainees or other occupational safety and health
professionals related to disparities in vulnerable worker populations. Residents will be
encouraged to focus on work-related health concerns as outlined in Healthy People 2030.
Continued support from NIOSH will enable us to train at least 2 residents per year, one from
each level of training, over the funding cycle, and will allow us to offer a wide array of
opportunities that will enhance residents' training and professional development. While the
residency has been able to train up to 6 residents per year over the last 8 years, all trainees
selected will be included in the training opportunities as outlined. Support from this funding will
be adjusted to provide support equally across trainees based on available award and trainee
level. We will continue to select high quality candidates of diverse backgrounds, who have a
passion for service of underserved populations, and will become productive members of the
profession.
Additionally, this NIOSH funding opportunity along with other grant support will allow for the
Occupational Medicine residency to confidently request an increase in trainee complement to up
to eight residents per year. This increase will serve to improve the growing concern of a dearth
of occupational medicine trained physicians that are entering into the workforce and ready to
meet the intensifying demand of employers and employees globally.

Public health relevance
Project Narrative Public Health Relevance Statement The Meharry occupational medicine residency program provides high quality training opportunities that will produce exceptional occupational medicine physicians who will positively impact the health of workers and their communities. The importance of this training rests on the continually increasing demand for highly skilled occupational medicine physicians who can effectively address the health needs of a growing and diverse US workforce and ensure the highest standards of occupational health and safety are met. In keeping with the mission of Meharry, the training competencies are geared towards attaining knowledge and skills necessary for serving the healthcare needs of underserved populations.